Lingual muscle control of upper airway patency in obstructive sleep apnea

Project Summary
Obstructive sleep apnea (OSA) is a major source of cardiovascular morbidity and mortality for which conventional
treatment is poorly tolerated and effective pharmacotherapy is lacking. Efforts to develop pharmacotherapy have
been hindered by a lack of fundamental insight into neuromuscular mechanisms causing upper airway
obstruction during sleep. Our proposal will address this gap by elucidating distinct effects of lingual muscles on
upper airway patency in OSA patients. Our central hypothesis is that synergistic effects of lingual muscles
are required to overcome specific defects in upper airway structural and neuromotor control and restore
pharyngeal patency. This hypothesis challenges the long-held concept that the genioglossus is a major
pharyngeal dilator muscle responsible for the maintenance of pharyngeal patency during sleep. It rests instead
on strong evidence that several lingual and pharyngeal muscles control distinct mechanical determinants of
pharyngeal patency during sleep. In SA1, we will elucidate specific mechanisms for synergistic control of
pharyngeal patency by stimulating lingual protrudor and retractor muscles, and will elucidate distinct physiologic
mechanisms for synergy between these muscle groups during drug-induced sleep endoscopy (DISE, SA1). In
SA2, we will determine the impact of lingual muscle synergy on the maintenance of airway patency in NREM
and REM sleep. In both SAs, we will test the impact of anatomic constraints on stimulation responses. We
hypothesize that protrudors are required to decompress peri-pharyngeal tissues and dilate the pharynx, whereas
co-activation with retractors further decrease pharyngeal collapsibility by stiffening the tongue and fixing its
position. Our aims challenge the primacy of the genioglossus in the maintenance of airway patency during sleep.
The project seeks to develop novel strategies for targeting specific defects in the control of pharyngeal patency
by activating specific lingual muscles that relieve pharyngeal obstruction during sleep. This project outlines
rigorous approaches for establishing synergistic mechanisms between lingual protrudors and retractors, based
on our proven ability to activate these muscles independently. State of the art physiologic and imaging methods
will be deployed to probe effects of muscle stimulation, sleep state, and anatomy on the control of pharyngeal
patency. Our findings will (1) transform our understanding of upper airway neuromuscular control during sleep,
(2) establish relevant neuromotor targets for electro-stimulation and pharmacotherapy, and will (3) identify
potential physiologic and anatomic predictors of therapeutic success when these strategies are deployed. In
leveraging a unique combination of translational approaches, we will demonstrate specific strategies for
activating lingual muscles and stabilizing airway patency during sleep in apneic patients.

Public health relevance
Project Narrative This proposal will develop novel approaches for treating patients with obstructive sleep apnea, a major source of cardiovascular morbidity and mortality in Western societies. It leverages a unique combination of translational approaches to demonstrate strategies for co-activating specific lingual muscles that relieve pharyngeal obstruction in apneic patients with the long-term goal of fueling pharmacologic initiatives for treating this disorder.